EPR: CYSTEINE BASED RADICAL IN MERCATOPYRUVATE INACTIVATED PYRUVATE FORMYL LYASE

Mercaptopyruvate added to activated PFL generates two sulfur based radicals thereby inactivating the enzyme. For one of the radicals, hyperfine coupling to a single ~-methylene hydrogen of a disulfide radical is indicated. Deuteration of cys 418 and 419, residues required for catalysis, changes the EPR consistent with the radical being formed on a cysteine residue of the protein. Mutant enzymes C418S and C419S do not form the radical species observed.